Neutrophil Decision Making in Confined Environments in Health and Disease

Sepsis diagnosis poses significant clinical and scientific challenges. The incidence of sepsis in the US is twice
the rate of congestive heart failure, six times the rate of colon cancer, and 20 times the incidence of AIDS, and
sepsis is the single most significant expense in Medicare budget. Early and more accurate diagnostic of sepsis
could save lives, reduce costs, and improve treatment. However, the precision of early sepsis diagnosis today
is ~70% (one in every three patients is misdiagnosed). Blood cultures are the gold standard, but their results
are available 3-4 days after clinical decisions have been made. Towards the goal of early and accurate sepsis
diagnosis, we will focus on microfluidic tools that measure neutrophil inflammatory and anti-microbial functions.
We will pursue three enabling technologies to better understand the functionality of neutrophils in the context of
sepsis. We will increase the sensitivity and reduce the duration of a new assay for sepsis based on the
spontaneous neutrophil migration, we will make precision measurements of neutrophil cooperation against live
microbes using new swarming arrays, and we will design devices to trap neutrophil-derived chromatin from
blood (cNETs) and identify bacteria in blood during sepsis.

Public health relevance
Although today the absolute neutrophil count (ANC) is the most prescribed test in the clinic, our understanding of how neutrophils' functions change during diseases is limited. To close the significant gap that exists between the importance placed by clinicians on neutrophils and our understanding of their role during disease, we will pursue three new technologies designed to study neutrophils in the context of sepsis. We will increase the sensitivity and reduce the duration of a new assay for sepsis, will make precision measurements of neutrophil cooperation against microbes during swarming, and we will rely on neutrophil derived chromatin to identify bacteria in blood during sepsis.